Structure and Specificity of Restriction-Modification (R-M) Systems

Abstract
Under the parent grant NIGMS R35-GM131780, titled “Structure and specificity of restriction-modification
(R-M) systems”, this application is a supplemental request to replace an aged FPLC system that has been
discontinued and is no longer supported and serviced by the vendor. All of the structural studies performed
under the parent grant are heavily reliant on protein purification – a necessary prerequisite for X-ray
crystallography and cryo-EM. The request is for an AKTA pure 25 M system with a Micro kit that will be 1)
fully supported and serviced by the vendor, 2) allow the purification of proteins to be monitored at more than
one wavelength, which is important because the aims of the parent grant are centered on DNA and RNA
binding proteins, and 3) permit the purification of proteins on a microscale, which is essential, especially as
the aims of the parent grant continue to grow in the direction of cryo-EM.

Public health relevance
Narrative This application is a supplemental request to replace an aged FPLC system that has been discontinued and is no longer supported and serviced by the vendor. All of the structural studies performed under the parent grant (R35-GM131780) are heavily reliant on protein purification. The requested instrument will be fully supported and serviced by the vendor and provide us additional capabilities to achieve the goals of the parent grant.